Identifying driver non-coding alterations in metastatic prostate cancer from tumor and cell-free DNA

Project Summary/Abstract
Dr. Gavin Ha is a postdoctoral research fellow in the laboratory of Dr. Matthew Meyerson at Dana-Farber Cancer
Institute and the Broad Institute of MIT & Harvard. His long-term career goal, in alignment with the mission of the
NCI, is to reduce cancer-associated mortality by determining the mechanisms driving cancer progression and
treatment resistance, developing cancer diagnostics, and identifying candidate therapeutic targets. To
accomplish this goal, Dr. Ha will integrate computational biology, genomics, and molecular biology approaches
to study advanced cancers from both tumor and liquid biopsies.
Late-stage advanced cancers lead to the majority of cancer-related deaths. Metastatic castration-resistant
prostate cancer (mCRPC) is an example of a disease that is lethal with no curative treatment. There are few
whole genome studies of mCRPC because tumors are often less accessible. Recently, Dr. Ha and others have
discovered alterations of DNA enhancer elements driving the expression of oncogenes. Thus, there is an urgent
need for deeper analysis of cancer genomes, beyond coding regions, to uncover new non-coding alterations
driving cancer progression. This proposal will address these challenges by building the necessary analytical
tools to characterize the whole genomes of metastatic cancers from both tumor and liquid biopsies. In Aim 1, Dr.
Ha will develop novel computational approaches to analyze linked-read sequencing, a new technology that
provides long-range genomic data, to more accurately characterize alterations in tumor genomes. In Aim 2, he
will use cell-free DNA from patient blood as a means to non-invasively access large cohorts of patients to detect
tumor-specific alterations. Then, in Aim 3, he will analyze both tumor and cell-free DNA to identify non-coding
genomic alterations affecting regulatory elements in mCRPC patients. He will perform longitudinal analysis from
blood samples collected during treatment to identify alterations that may be implicated in resistance. These
proposed projects will create much-needed analytical methods for emerging technologies to analyze tumor and
cell-free DNA and will provide insights into the mechanisms underpinning treatment resistance in mCRPC.
The K22 award will allow Dr. Ha to further enhance his ability to perform cutting-edge cancer research by
acquiring knowledge in techniques of molecular biology through scientific collaborations. The proposed
development plan will enable him to become a well-rounded independent investigator and to prepare him to lead
a multi-disciplinary group with expertise in computational and experimental aspects of cancer research. Dr. Ha
has access to an outstanding research environment, state-of-the-art facilities, and high-performance computing
at the Dana-Farber Cancer Institute and the Broad Institute. Dr. Ha is expecting to obtain an independent position
at a research institution with the same world-class facilities and intellectual environment.

Public health relevance
Project Narrative Alterations in the DNA are prevalent in cancer cells. This proposal aims to provide insights into how these alterations arise, how they contribute to cancer progression, and whether they can be observed from the blood. This work will help to design new cancer therapies and to enable minimally-invasive monitoring of patient response to treatment.